Administrative and Biostatistics Core

The purpose of this core is to provide the needed administrative support for the research effort in the Program Project. This core coordinates all of the research activities and meetings, provides planning support for development of new research protocols, provides budget planning and oversight, and provides the interface between the investigators and the institutional administrative procedures for personnel and operations.